EVALUATION OF NEONATAL HYPOTHALMIC-PITUITARY ADRENAL FUNCTION AFTER CHRONIC STER

To determine when the suppressed adrenal axis recovers in premature infants after steroid therapy for chronic pulmonary disease.